Estradiol signaling pathways mediating sex differences in striatal synaptic plasticity

Substance use disorders affect ~15% of the population, with gender differences in all stages of substance use.
Female sex-steroid hormones explain some of the disparity, such as accelerated transition from casual use to
addiction, as estradiol produces sex-specific differences in rodent learning and cocaine self-administration.
Prolonged cocaine use is known to engage dorsal striatal circuits. Synaptic plasticity in such circuits is critical
for a variety of types of reward learning, highlighting the potential role such plasticity could play in substance
use disorders. Thus, understanding sex differences in cocaine use requires determining how estradiol impacts
molecular signaling and synaptic plasticity in the dorsal striatum. Our preliminary results show that estradiol,
acting at estradiol receptor type α, impairs long term potentiation (LTP) in dorsomedial striatum (DMS) in
estrous females; however, the cell type in which estradiol acts has yet to be identified. Striatal spiny projection
neurons (SPNs) are either direct pathway SPNs, which promote action, or indirect pathway SPNs, which inhibit
action, and changes in these SPNs are critical for various behavioral consequences. Thus, it is essential to
understand LTP deficits in both direct and indirect pathway SPNs. In this proposal, we will test the hypothesis
that estradiol impairs LTP in indirect pathway SPNs in the DMS. LTP in the dorsal striatum critically depends
on activation of extracellular regulated kinase (ERK), which also is modified by both cocaine and estradiol.
Estradiol enhances cocaine-mediated dopamine release and interacts with metabotropic glutamate receptors
to modify ERK activation, but an unbiased approach is needed to determine whether estradiol impacts other
signaling pathways. Our preliminary results have identified several signaling pathways that are modified by
estradiol; however, a critical question is how cocaine interacts with estradiol to modulate these signaling
pathways. We propose cutting-edge molecular and transgenic approaches combined with novel computational
modeling to test the hypothesis that estradiol-mediated changes in gene expression impair LTP and to
determine how cocaine further modifies the signaling pathways underlying synaptic plasticity. In Specific Aim
1, we perform electrophysiology in transgenic mice to determine whether LTP is impaired by estradiol in one or
both SPNs. In Specific Aim 2, we use innovative techniques of single nuclei RNA sequencing, translating
ribosome affinity purification followed by RNA sequencing and spatial transcriptomics to identify signaling
pathways modified by estradiol and cocaine self-administration in a cell-type specific and spatial manner. In
Specific Aim 3, we use innovative, data-driven modeling of signaling pathways followed by model-driven
experiments to causally test which interactions between critical signaling pathways produce estradiol-mediated
deficits in LTP. Successful completion of the proposed research will delineate how estradiol influences synaptic
plasticity in dorsal striatum, including in conjunction with cocaine, and provide a foundation for future work to
understand sex differences in reward learning and the consequences of cocaine use.

Public health relevance
Female sex hormones contribute to gender differences in many aspects of substance use disorders, such as accelerated transition from casual use to addiction. Synaptic plasticity in dorsal striatal circuits is critical for reward learning and substance use behavior, and this plasticity is impaired by female sex hormones. Understanding how estradiol interacts with cocaine to modify mechanisms underlying synaptic plasticity in the dorsal striatum can illuminate mechanisms underlying gender differences in behavior and help to identify methods for improving treatments in females.